Biostatistics and Bioinformatics Core

Project Summary/Abstract
The overall goal of the Biostatistics/Bioinformatics Core (Core B) is to provide state-­of-­the-­art biostatistics
and bioinformatics support to ensure the rigor of the science and operations within the Cervical SPORE by
participating fully in the design of preclinical studies and clinical trials, validation of assays and data systems,
quality control of data and specimen management, and the statistical analysis, interpretation, presentation and
sharing of data by consultation and collaboration throughout our infrastructure at the Johns Hopkins University
(JHU), University of Alabama at Birmingham (UAB), and the University of Colorado at Boulder. Core B will
provide centralized biostatistical and bioinformatics services as well as collaborative research and data
management support for the research projects of the SPORE. Core B will serve as the focal point from which
the SPORE investigators, including developmental pilot project and career enhancement program awardees, to
draw upon statistical expertise for their research projects. The Specific Aims of Core B are to (1) provide
biostatistics and bioinformatics consultation and support by assisting in experimental design and data collection,
visualization, analysis, quantitative modeling, interpretation, and publication for all SPORE projects;; (2) provide
biostatistics and bioinformatics support for the Tissue/Pathology/Immunology Core (Core C), the
Developmental Research Program (DEP) awardees, and the Career Enhancement Program (CEP)
awardees;; and (3) to develop new or adapt existing biostatistics and bioinformatics methods as needed and
appropriate. Core B will also provide assistance with the identification and solution of complex database tasks
arising in the course of project activities. This includes integration of clinical and basic research databases and
interfaces for data entry, data retrieval, patient or sample tracking, and procedures to ensure data quality,
integrity, and confidentiality. This web-­based database will provide a centralized means to produce interim
reports of projected progress, patient accrual, processing of specimens, completeness of data gathering, and
monitoring of patient drop out or loss to follow-­up. Core B is led by Drs. Chenguang Wang, Ph.D. (JHU), Sejong
Bae, Ph.D. (UAB), and Anne Rositch, M.S.P.H., Ph.D. (JHU), and further supported by co-­investigator Dr. Sarah
Wheelan, M.D., Ph.D. (JHU). All projects, including those within the CEP and DRP, and other cores of the
SPORE will be supported by Core B.

Public health relevance
Project Narrative The Biostatistics/Bioinformatics Core (Core B) will provide state- of- the- art biostatistics and bioinformatics support to ensure the rigor of the science and operations within the Cervical SPORE by participating fully in the design of preclinical studies and clinical trials, validation of assays and data systems, quality control of data and specimen management, and the statistical analysis, interpretation, presentation and sharing of data by consultation and collaboration throughout our infrastructure at the Johns Hopkins University, University of Alabama at Birmingham, and the University of Colorado at Boulder.